Environmental Statistics and Biostatistics Core

ENIRONMENTAL STATISTICS AND BIOINFORMATICS CORE
ABSTRACT
The Environmental Statistics and Bioinformatics Core (ESBC) provides a wide range of
support in biostatistics, statistical genetics and genomics, bioinformatics, and data science
for investigators associated with the Harvard Chan-NIEHS Center for Environmental
Health. Assistance is also available in several other specialized areas including
environmental epidemiology and statistical modeling of spatially and temporally
referenced data. In addition to design and analysis support, Core faculty and staff advise
investigators on principles as well as statistical and computational tools for reproducible
science, including data management, large-scale research computing infrastructure, and
analysis pipelines. Further, Core members provide statistical training for faculty, graduate
students, and fellows working on Center-related projects. Core faculty and researchers
engage in mission-related methodological research motivated by questions and
methodological challenges, providing freely available software to Center members and the
broader environmental health community. Having this Core enables us to provide
specialized services particularly relevant to environmental health issues, such as
statistical genomics and bioinformatics. It also gives us the necessary support to be able
to offer educational activities such as 1:1 individual meetings with (junior) investigators,
focused working groups that tackle common problems, and holding relevant seminars.
We are able to leverage our Center support with University resources to maximize our
services to Center members.